Collaborative Justice-Involved Research and Training Program on Substance Use and HIV at Brown University Health

ABSTRACT
Involvement with the justice system, substance use, and infection with HIV and hepatitis C virus (HCV) are
syndemic in the United States (U.S.). Persons involved with the justice system are more likely to have substance
use disorders (SUD), comorbid mental health conditions, limited access to health care, and have higher rates of
HIV, HCV infection, and other infectious diseases than the general population. Research exploring these
phenomena and their impacts on health outcomes are insufficient. To address these disparities and increase the
number and capacity of scientists working with justice populations, we established The Lifespan/Brown Criminal
Justice Research Program on Substance Use and HIV (referred to as CJRT) in 2015. Now in the 10th year of
funding, CJRT program is seeking a second renewal (years 11-15) to sustain this unique, innovative, and highly
successful program. The CJRT program recruits an annual cohort of 5-6 scholars consisting of post-doctoral
fellows, junior faculty researchers, and occasional exceptionally qualified pre-doctoral students, from the U.S.
The program is led by an experienced team of NIH-funded investigators who collectively have several decades
of experience conducting research among justice-involved populations within local, national, and international
settings; and who have extensive mentoring experience with early-career and early-stage investigators. The
mission of the CJRT program is to prepare scholars for independent NIH-funded clinical research careers
focused on improving health outcomes related to substance use, HIV, HCV, and related co-morbidities among
persons who are involved with the justice system. The educational program is comprised of didactic education,
mentored research, and experiential learning. CJRT scholars are enrolled for a two-year period and pursue
research at their home institution under the guidance of both local and CJRT mentors. The program has the
following three aims: 1) provide scholars with a solid foundation for conducting research in justice populations
that includes skills in research methodology, scientific writing, grant writing, dissemination, and the ethics and
practice of conducting research among vulnerable populations; 2) provide professional mentorship and guidance
to support the career advancement of junior investigators; and 3) provide a mentored research experience
including funds for pilot studies that provides a supportive pathway to research independence. Pilot funding
enables scholars to gather preliminary data to support future NIH grants, and the opportunity to disseminate their
findings at national meetings and through the peer-reviewed literature. Following completion of their training,
scholars are retained in a robust network of CJRT-affiliated investigators that fosters ongoing mentorship,
research collaboration, and professional growth. For the next funding period, the CJRT will add research to
explore innovative approaches to improve HIV and SUD outcomes among justice populations in Ending the HIV
Epidemic (EHE) priority jurisdictions; and 2) introduce and support health economics research to inform the
overall research agenda and policies aimed at HIV, SUD, and co-morbidities among justice populations.

Public health relevance
PROJECT NARRATIVE Involvement with the justice system, substance use, and infection with HIV and hepatitis C virus are syndemic in the United States. Despite this public health crisis, there is a relative dearth of research aimed at improving treatment outcomes among justice-involved populations. To address this gap and increase the number and capacity of research scientists working with justice-involved populations, we have established this clinical research training program based at Lifespan/Brown University and in collaboration with the Brown University, Boston Medical Center, Duke University, and Tufts Medical Inc.